PHARMACOKINETIC ASSESSMENT OF THYROGEN IN THYROID CANCER

This multicenter study is designed to determine the pharmacokinetic profiles of recombinant human TSH when administered to patients with thyroid cancer that has been successfully ablated.